Developmental Research Project Program

Project Summary/Abstract Developmental Research Project Program (DRPP) Component
The Developmental Research Project Program (DRPP) will select and support the most promising and
meritorious biomedical research in Idaho. The INBRE-4 broad and inclusive scientific theme, Cell Signaling,
will best serve investigators from a variety of research areas. The DRPP integrates well into the programmatic
goals of the Overall Component Specific Aims 2 and 5 by providing research opportunities to faculty and
students that meet high standards of research excellence. An estimated pool of 700 faculty is eligible for the
DRPP. To accommodate diverse research/teaching appointments, three stratified levels of faculty research
participation, each with specific obligatory milestones, will be available. The top-tier, a DRP Investigator,
requires >50% research effort. An “on-ramp” (tier-two) to this level is a Pilot Project Investigator, requiring
>25% research effort. Although faculty at the research-intensive institutions are eligible, emphasis will be to (i)
strengthen the research environment at the primarily undergraduate institutions (PUIs), (ii) integrate research
into the PUI educator's career, and (iii) expose PUI students to meritorious research. To further encourage
research at the PUIs and community colleges, a third-tier of participation will be the Student Research Mentor
(<20% research effort). These educators have established or newly developing projects that focus on providing
students with high-impact participatory research experiences. Scientific Mentor/Advisors will provide guidance
and ensure productivity milestones are met. Investigators will be recruited through an internal statewide INBRE
funding opportunity announcement (FOA). The tier-one application will use the NIH R15 template to propose a
problem, its significance, give background, a hypothesis, specific aims, experimental approach, expected
outcomes, pitfalls, and alternatives. The Pilot Project and Student Research Mentor proposals will be
abbreviated applications. All will include biosketches, justified budgets, and meet federal compliance
requirements. External scientific review scores/recommendations will be vetted by the statewide Steering
Committee (SC) and the External Advisory Committee (EAC). Meritorious projects will be prioritized based on
review score, participant diversity, available INBRE infrastructure, and NIGMS approval. The effective INBRE-3
policies and practices for solicitation, submission, external review by a panel of experts, selection criteria, and
prioritization of awards will continue. This successful approach funded 120 projects over four years, yielded 20
new NIH grants (+14 pending), and 158 new non-NIH awards. These projects generated 262 scientific
publications, 374 national presentations, and mentored 699 students. Additional INBRE-4 initiatives will include
(i) a regional alliance (RAIN) with Montana and New Mexico INBREs and (ii) DRPP investigator-responsive
short duration funding. Statewide benefits to the lead and partner institutions from the DRPP investments will
be measured, tracked and evaluated to justify and adjust this approach. Assessment will be done by the
Evaluation Director, ad hoc reviewers, SC, EAC, and by a commissioned end-of-year-two external review.